Small Molecule Screens to Identify Probes for Studies of Repair and Regeneration

DESCRIPTION (provided by applicant): The zebrafish is an important genetic model for studying embryonic patterning and organogenesis. Although genetic tools are available to probe gene function and signaling pathways during embryonic development, their utility is limited with temporally tightly controlled processes or with genes whose perturbation results in embryo lethality. Small molecule probes can overcome these obstacles due to their rapid and reversible actions, thereby enhancing genetic studies and offering a unique opportunity to uncover the roles of signaling pathways in larval and adult physiology. Currently, methods to study gene function in adult zebrafish involves the generation of transgenic heat shock driver lines, the use of binary gene activation such as the Gal4-UAS system, or the use of genetic recombination such as Cre recombinase to activate gene expression. Sophisticated tissue specific gene knockouts are not currently feasible in zebrafish, thus limiting the study of signaling pathways to early development, when gene products can be knocked-down with antisense oligonucleotides. The objective of this proposal is to identify novel small molecule modulators of the FGF and TGFß pathways as tools to dissect the role of these signaling pathways in zebrafish larval and adult repair and regeneration. The FGF and TGFß signaling pathways are critical in regeneration, repair, and wound healing but their exploitation as potential pharmacological targets awaits elucidation of their precise molecular mechanisms during these events. Small molecules that hyper-activate these pathways would be useful tools to study the roles of these pathways and represent starting points for the development of novel regenerative therapies. Ultimately, we will provide the zebrafish community with a unique set of tools to study later stages of development and adult zebrafish models of disease. These studies will provide validated probes for enhancing FGF and TGFß signaling with defined specificity and in vivo activity in models of tissue repair and regeneration. The proposed work is divided into three specific aims, which take advantage of the complementary expertise of investigators on this multi-PI proposal. Aim 1: We will identify compounds that activate the FGF signaling pathway. Aim 2: We will identify compounds that activate the TGFß signaling pathway. Aim 3: We will test the efficacy of the new compounds in regeneration models that are commonly used in our laboratories.

Public health relevance
The objective of this proposal is to identify novel small molecule modulators of the FGF and TGFß pathways as tools to dissect the role of these signaling pathways. One major obstacle associated with studying zebrafish regeneration in larvae and adults is the limited number of means to functionally suppress or enhance these pathways in this process. To overcome these shortcomings, treatment with small molecules that suppress or enhance these signaling pathways is a desired approach. The ultimate goal is to provide the zebrafish community with unique set of instruments for studying the FGF and TGFß signaling pathways.